Clinical Trials Network: Pacific Northwest Node (CTN-0082, -0131, -0139 and dissemination library)

Evolving trends around opioids, methamphetamine, legalized cannabis, and stigma have led to prioritization of several themes in addiction treatment research. Innovations in MOUD treatment, overdose prevention, harm reduction strategies, and novel therapeutics and technologies are needed to address the leading challenges in SUD treatment. To carry out to the objectives and research priorities of the NIDA Drug Abuse Treatment Clinical Trials Network (CTN), the Pacific Northwest (PNW) Node proposes the following Specific Aims: 1) Increase capacity of the PNW Node research team by expanding investigators who bring practical and clinical expertise and an encompassing lens to their work in opioid, methamphetamine, and other drugs of abuse; substance use impacts on youth and families; emerging behavioral, neuromodulation and pharmacologic treatments; SUD treatment access in primary care (PC); and harm reduction strategies. 2) Expand scope, population, and focus of PNW Node’s roster of research, practice, and dissemination settings. We will do this by including new settings for SUD treatment and PC, and partnerships with individuals and organizations focusing on drug and alcohol related policy in the Pacific Northwest. 3) Design and conduct pragmatic, comparative effectiveness, implementation, data science, and other types of studies that evaluate novel behavioral, pharmacological, and technology-based treatments for opioids, methamphetamine, and cannabis. Studies will be informed bi-directionally by SUD researchers, clinicians, primary and acute care providers and our community advisory board, and enhanced where appropriate by use of Electronic Health Records to ensure representation of all groups. 4) Provide dissemination, workforce training, and technical assistance to affiliated SUD and healthcare providers, researchers, and the public about SUDs, medication treatments, and behavioral interventions integrated into settings serving people who use substances. We will use strategic cross-node collaborations and UW/WSU training, technical assistance and dissemination programs to complete this work.

Public health relevance
Many people with substance use disorders (SUDs) do not seek treatment through specialty SUD programs. Instead, integrating SUD treatment and harm reduction services into community settings is an efficient way to bring those services to people with co-occurring medical and mental health conditions. Research on improved treatments and technologies is needed, to better deliver SUD-related services in primary care, acute care, remote-rural, low barrier, and specialty medical settings.